EFFECTS OF SEROTONERGIC MECHANISMS ON HUMAN SLEEP IN HEALTH AND DISEASE

5HT1A receptor agonists decrease rem sleep in normal controls and animals. In order to test the hypothesis that patients with depression have down-regulated 5ht1a receptors, it is predicted that they will show less inhibition of rem sleep following challenge with ipsapirone, a 5ht1a receptor agonist, than normal controls.